Blood vessel assembly from multipotent hemangioma-derived stem cells

Project Abstract
Infantile hemangioma (IH) is a common vascular tumor with a unique lifecycle of rapid blood vessel formation
over the first 6-9 months of infancy, followed by a slow spontaneous involution of blood vessels over several
years. For most children, IH does not pose a serious threat and therapy is unnecessary; however, in about
10% of cases, IH can enlarge dramatically, threaten organs and cause permanent disfigurement. Over the last
10 years, propranolol, a well-known non-selective β-adrenergic receptor antagonist, has emerged as first-line
therapy for endangering IH, yet how and why it works so well in reducing the vascular overgrowth in IH has
remained a mystery. There is a significant need to improve propranolol therapy because up to 18% of IHs fail
to respond, up to 25% resume growth when the drug is stopped, and 37% of propranolol-treated infants require
surgery at 5-6 years of age to minimize deformity caused by remaining fibrofatty residua. To improve on
propranolol, it is essential to elucidate it’s mechanism of action against vascular overgrowth, which will then
provide a path forward to advance IH medical therapy, and potentially other neovascular diseases as well.
In previous funding cycles, we identified a hemangioma stem cell (HemSC) from human IH surgical specimens
that can differentiate into endothelial cells, pericytes and adipocytes and form hemangioma-like vessels within
7 days when implanted into immune-deficient mice. Subsequent studies from our lab and others validate
HemSCs as the IH-initiating cell. Our recent results show that a small molecule inhibitor of the transcription
factor SOX18 and propranolol both effectively block HemSC-to-endothelial differentiation. Furthermore, the
R(+) enantiomer of propranolol, which lacks β-adrenergic receptor antagonistic activity, is equally effective.
This novel discovery identifies a β-adrenergic receptor-independent, SOX18-dependent mechanism by which
propranolol reduces vascular overgrowth in IH. To investigate deeply, we propose three specific aims. Aim 1
will directly and rigorously test the requirement for SOX18 in IH vessel formation using our in vivo model in
which IH-derived HemSC form IH-like blood vessels in nude mice. Aim 2 will investigate dimerization status of
SOX18 in IH (sub-aim 2a), how propranolol and the R(+) enantiomer disrupt SOX18 dimerization and sub-
cellular localization (sub-aim 2b), and how this alters transcription to prevent HemSC-blood vessel formation
(sub-aim 2c). Aim 3, conducted in parallel, will analyze our existing next generation sequencing data using
new bioinformatic tools to identify potential chromosomal translocations or small copy number variants that
could produce fusion transcripts with new activities (sub-aim 3a) and will perform deep coverage RNA-Seq on
IH tissue and freshly isolated IH cells as an alternative method to identify fusion transcripts (sub-aim 3b); once
identified, the connection to SOX18 and IH vessel formation will tested in in vitro and in vivo models.

Public health relevance
Project Narrative Infantile hemangioma, a benign vascular tumor that occurs in 4-5% of children, is treated with propranolol, yet why and how propranolol is effective has remained a mystery. We have new data that uncovers a novel, unexpected mechanism of action for propranolol. In this proposal we will deeply study how propranolol reduces vascular overgrowth in infantile hemangioma with the goal of improving treatment options for infantile hemangioma, and potentially other diseases where vascular overgrowth occurs.